The Role of Keratinocytes and TRPM3 in CIPN Pain

Project Summary
Individuals on chemotherapy often face debilitating side effects, including chemotherapy induced peripheral
neuropathy (CIPN). Up to 60-90% of patients with cancer on paclitaxel (PTX), report signs of CIPN; these
symptoms include both mechanically evoked and spontaneous, ongoing pain. Although much of the previous
literature on CIPN has focused on the dorsal root ganglion (DRG) neurons we have recently shown that non-
neuronal cells of the skin epidermis, keratinocytes, also contribute to CIPN-induced mechanical pain.
Compared to mechanical pain, almost nothing is known about the causes of ongoing pain, and nothing is
known about the contribution of keratinocytes to non-evoked, ongoing pain. My preliminary data suggests that
after PTX administration, mice display non-evoked pain behaviors. Additionally, my analysis of single cell
sequencing of mouse hind paws following PTX treatment revealed a potential role of TRPM3. Here, I propose
to investigate the role of keratinocytes, and TRPM3, in pain behaviors using a mouse model of CIPN. In Aim 1,
I hypothesize that keratinocytes contribute to ongoing pain behaviors in CIPN mice. I plan to test this
hypothesis by observing ongoing pain behaviors in mice after inhibition of keratinocytes (1A). Then I plan to
utilize a method to measure spontaneous activity of DRG neuron afferents of CIPN mice ex vivo following
keratinocyte inhibition using teased fiber recordings (1B). In 1C, I will use a coculture of keratinocytes and
DRG neurons to measure electrophysiological properties of DRG neurons following PTX exposure using patch
clamp recording. In Aim 2, I hypothesize that the TRPM3 channel contributes to pain behaviors in CIPN. I
will test this hypothesis by exposing Trpm3-/- knockout mice to PTX and use a battery of behavioral assays to
assess pain-like behaviors (2A). I will use calcium imaging to determine if TRPM3 is sensitized in DRG
neurons and in keratinocytes (2B). Finally, I will test whether Trpm3-/- knockout mice DRG neurons display
spontaneous activity following CIPN using patch clamp electrophysiology (2C). These aims will provide insights
into the mechanisms of ongoing pain and will interrogate a potential target to alleviate paclitaxel induced CIPN
pain.

Public health relevance
Project Narrative: Keratinocytes, the cells comprising the outer layer of skin, have recently been shown to be essential in transmitting normal and painful touch information to the sensory neurons that innervate them. This proposal will explore the role of keratinocytes, and a specific ion channel, TRPM3, in chemotherapy induced pain. Understanding how keratinocytes and TRPM3 mediate different aspects of chemotherapy-induced pain will set the foundation for future development of novel topical therapies that relieve the side effects of chemotherapy, potentially improving the quality of life of hundreds of thousands of patients with cancer diagnoses.